Methotrexate effects on synaptic plasticity: a path to female resiliency to chemotherapy-induced cognitive deficits

Abstract. Homeostatic synaptic plasticity (HSP) is an adaptive, stabilizing response to prolonged
changes in network activity that is necessary for proper functioning of the nervous system. HSP is
becoming recognized as a critical form of plasticity involved in neurodevelopment, cognition, and
emotional regulation, that, when it becomes dysregulated, may contribute to pathological states.
The chemotherapeutic agent, methotrexate (MTX), is used to treat most pediatric patients
with acute lymphoblastic leukemia (ALL), the most common form of childhood cancer. The
effectiveness of MTX-treatment has resulted in a growing number of survivors, yet MTX exposure
is closely associated with executive function deficits in survivors, establishing a pressing need to
define the mechanisms that link MTX exposure to cognitive dysfunction.
To identify these mechanisms, we have developed a more translationally-relevant mouse
model of early life exposure to cancer+chemotherapy. We find cognitive deficits in exposed
animals (demonstrating construct and face validity of our model), that are sex and dose (of MTX)
dependent, with increased vulnerability in males. Further, we find altered gene expression in
astrocytes, with significantly more differentially expressed genes in females, with notable
alterations in genes related to GABA signaling. Importantly, we have new preliminary data showing
that prolonged MTX exposure in vitro results in an HSP-like decrease in synaptic strength. These
preliminary data lead to our hypothesis that chronic exposure to MTX affects astrocyte function in a
sex-dependent manner resulting in synaptic remodeling and HSP-like changes in females and not
in males, which may explain female resiliency to chemotherapy-induced cognitive deficits in our
animal model.
The goal for this R21 application is to use functional and structural techniques (patch-clamp
electrophysiology and immunohistochemistry, respectively) in vitro (the standard model for
studying HSP) and in vivo to determine whether MTX drives changes in neuronal physiology, and
whether these responses vary by sex. The proposed studies are conceptually innovative, as (1)
effects of chemotherapy on synaptic physiology have not been studied and (2) sex differences in
HSP remain wholly unexplored in the literature. Data from the proposed experiments could open
new directions for the treatment and/or prevention of chemotherapy-induced cognitive deficits in
children and highlight the importance of inclusion of SABV in HSP experiments.

Public health relevance
Narrative Synaptic plasticity is the ability of neurons to adapt to changes in network activity and is required for proper functioning of the nervous system. Survivors of childhood cancer that were treated with chemotherapy early in life often report problems with memory and executive function (attention, planning). To understand how brain cells (neurons) are changed by chemotherapy, cultured mouse neurons and brain slices will be tested for functional and structural changes and compared between sexes.